GROWTH HORMONE SECRETION IN BURN INJURY

Patients with burn injury will likely have an elevated serum growth hormone on presentation which will become suppressed during standard therapies for burn injury. Twenty patients with burn injury will be studied on admission and for at least 2 weeks to characterize serum GH secretion during burn injury.